CAMP-DEPENDENT TRANSCRIPTIONAL REGULATION OF CYP51

The long term goal of collaborative research between the P.I. and the foreign collaborator is to determine the role of the high level expression of CYP51 (lanosterol 14alpha-demethylase cytochrome P450) in haploid, postmeiotic germ cells. This FIRCA proposal addresses a portion of this overall goal and will lead to an understanding of the biochemical mechanisms involved in cAMP-dependent transcription of CYP51 in somatic and germ cells. The specific aims for the proposed three years are to study cAMP- dependent transcriptional regulation of CYP51 in steroidogenic (somatic) cells (Aim 1) and in haploid germ cells (Aim 2). The parent grant (DK28350) addresses ACTH (cAMP)-dependent transcription of genes (particularly encoding P450 enzymes) in the adrenal cortex, a process essential for maintenance of optimal steroidogenic capacity. Aim 1 is an extension of DK28350 and will establish whether a link between cAMP-dependent transcription of genes encoding steroidogenic P450s (cholesterol metabolism) and CYP51 (cholesterol biosynthesis) exists in the adrenal cortex. It seems likely that two different signalling pathways, oxysterol/SRE and cAMP/CRE, interact to control CYP51 levels in steroidogenic cells. Preliminary data indicates that CYP51 is transcriptionally regulated by cAMP in haploid germ cells. Aim 2 is a new direction for studies in DK28350 and will establish the biochemical basis of this postmeiotic transcriptional regulation. Results from these studies will provide a more detailed understanding of steroid hormone biosynthesis which is a major path of cholesterol metabolism and of spermatogenesis in male reproduction.